Optimizing Implementation in Cancer Control: OPTICC

OVERALL SUMMARY
The mission of the OPTICC (Optimizing Implementation in Cancer Control) Center is to improve cancer outcomes
by supporting optimized implementation of evidence-based interventions (EBIs) in cancer control. Optimized
implementation occurs when: (1) the strategies employed to implement EBIs address the key barriers to
implementation that are active in the specific settings in which implementation occurs, and (2) those strategies
reflect the best possible methods for addressing the barriers. Despite two decades of progress in implementation
science (IS), practical tools and guidance to support optimized EBI implementation are lacking; as a result,
strategies are often mismatched to barriers and are often not optimized for effectiveness, efficiency, or fit with local
resources. The result is suboptimal implementation in the form of lost time, effort, and resources and, ultimately,
poorer cancer outcomes. The OPTICC Center will advance IS and, in turn, improve EBI implementation in cancer
control by developing, testing, and refining innovative methods for optimizing EBI implementation. The OPTICC
Center is a strategic collaboration of the University of Washington (UW), Kaiser Permanente Washington Health
Research Institute (KPWHRI), and the Fred Hutchinson Cancer Research Center (FHCRC). Three cores will
support its work. The Administrative Core will promote multidisciplinary collaboration, research excellence, and
methodological innovation. It will also lead Center outreach and dissemination efforts, evaluate Center impact, and
coordinate Center activities. The Research Program Core will conduct innovative implementation studies, method
and measurement studies, and small pilot studies that advance the Center’s “grand challenge” IS theme of
optimizing EBI implementation. A three-stage approach to optimizing EBI implementation will be taken—identify
and prioritize barriers, match strategies, and test strategies—with measurement development spanning all three
stages. The Implementation Laboratory Core will establish and coordinate a network of diverse clinical and
community sites to conduct “in vivo” IS studies, implement cancer control EBIs, and shape the Center’s research
agenda. The Center’s initial studies will focus on optimizing implementation of screening EBIs for cervical,
colorectal, breast, and ovarian cancer. However, the methods for optimizing EBI implementation that the Center
will develop, test, and refine can be applied broadly across the cancer care continuum, for a wide range of cancers,
to answer a wide range of IS questions.

Public health relevance
The proposed research is relevant to public health because the development and dissemination of practical methods for optimizing EBI implementation will support cancer control efforts in clinical and community settings and ultimately improve cancer outcomes. The relevance to NCI’s mission is ensuring that cancer control EBIs are effectively delivered and positively impact individuals at risk for cancer and those experiencing cancer.